Request fund to purchase equipment (the BioComp gradient primer) to supplement R15 GM139107-01

Project Summary (Abstract):
We are applying for a supplement fund to purchase a BioComp gradient primer for
fractionating density gradients. This equipment is essential for the success of the parent
award as several proposed experiments, including polysome profiling, ribosome
profiling, and Translating Ribosome Affinity Purification (TRAP), rely on this equipment
to receive consistent and reproducible results. We desperately need this equipment to
continue our investigation following equipment malfunction of our current system that
cannot be repaired (system age and non-availability of parts). Additionally, no other
laboratory at our institution has similar equipment we could share. Our talented
undergraduate and graduate students will use this equipment to address an exciting but
disputed question: does the functional specialization of ribosomes exist to support
selective translation? We focus on two paralogs of predicted large ribosomal subunit 27
(Rpl27) found in fission yeast. Although these paralogs have 90% amino acid similarity
and are highly conserved through much of eukaryotic evolution, their mutants
demonstrate distinct phenotypes. Our preliminary data suggest that they might be part
of heterogeneous ribosomes that regulate the translation of different mRNA transcripts.
Dissecting the functional differences between Rpl27 paralogs may provide valuable
insight into how ribosome protein paralogs potentially play a role in the heterogeneity of
ribosomes, inducing a conformational change that ultimately results in altered activity
and preference of mRNA transcripts accessible for translation.

Public health relevance
Narrative: 1) A new gradient fractionator is necessary and central to carry out the experiments of the funded project. 2) Practical training, use, and analysis of data associated with the gradient fractionator will directly contribute to the education and research training of highly intelligent, highly motivated BA, MA, and Ph.D. students destined for research careers in molecular biology and chemistry. 3) Availability of this modern equipment will enhance the research environment at Wake Forest University which is ranked #28 in the nation by USA Today College (https://www.usnews.com/best-colleges/wake-forest-2978).